High-throughput assays and small-molecule discovery of antiviral candidates targeting influenza hemagglutinin

PROJECT SUMMARY / ABSTRACT
Influenza A viruses exhibit extreme diversity as exemplified by the multiple serotypes of the hemagglutinin
(HA, H1-H18) and neuraminidase (NA, N1-N11) surface antigens. To date, only 3 of 198 possible combinations
of HA and NA in avian and other animal reservoirs have been associated with human pandemics (H1N1, H2N2,
H3N2). Recent appearances of H5N1, H6N1, H7N7, H7N9, H9N2, and H10N8 in humans are constant reminders
of the potential for devastating new pandemics. Influenza B viruses with its two lineages further increase the
health and economic burdens of seasonal influenza. No effective antiviral drugs are currently available for
preventing entry of influenza A or B viruses into host cells (scientific premise). However, relatively recent
discoveries of broadly neutralizing antibodies to human influenza viruses and concomitant structural studies
have identified sites-of-vulnerability on the HA in pandemic, seasonal, and emerging influenza viruses. These
HA surface sites include the receptor binding site and membrane-proximal stem housing the fusion machinery,
both of which are essential for cellular infection. Common features for recognition of these sites can now be
exploited in design of small molecules to ultimately develop broadly applicable influenza antivirals.
Here, we will employ this structural information into the optimization and execution of high-throughput assays
to identify new small-molecule scaffolds that target the highly conserved and vulnerable stem-binding site. High-
throughput screening will be performed in parallel on representative HAs from influenza A group 1 against 600K
structurally diverse molecules (SA1). We will also subject group 2 and influenza B HAs to a 300K compound
screen (SA2). Validated hit compounds will be prioritized based on affinity and breadth across HAs and top
candidates will be rigorously optimized into lead molecules by x-ray structure-based design cycled with medicinal
chemistry. Biophysical binding, cellular infectivity and resistance assays (e.g., combinatorial viral libraries of HA
mutants) will aid in iterative design, selection, and characterization of potential novel therapeutic candidates with
favorable drug-like properties. All of these methods are actively employed in the Wolan and Wilson laboratories.
As proof-of-concept for this approach, we identified a molecule with modest affinity to the stem of group 1 HAs
with an HT assay of our own design. Its co-crystal structure with HA provided critical information towards design
and synthesis of a focused compound library, which we used to produce a stereoselective molecule with
nanomolar affinity and antiviral activity. Our overall goal is to identify and improve molecules with broad potency
against the stem of groups 1 and 2 as well as flu B HAs. To our knowledge, we are the first to design an assay
against group 2 and flu B HAs amenable to HTS (innovation). We anticipate that several classes of stem-targeted
compound scaffolds will be identified with nanomolar affinity to HAs with cellular antiviral activity and suitable
PK-ADME properties. Future efforts will include animal models of influenza infections to further validate our
antivirals with the ultimate goal of combatting future influenza pandemics and seasonal epidemics.

Public health relevance
PROJECT NARRATIVE Structural studies of influenza hemagglutinin in complex with broadly neutralizing antibodies and designed inhibitors have established sites of vulnerability that are highly conserved across hemagglutinin subtypes. Here, we will develop and use novel high-throughput screening assays that permit the robust interrogation of the vulnerable and highly conserved site located within the hemagglutinin stem region of influenza A and B. Recurring recognition motifs and conserved pockets observed in our collection of HA crystal structures will provide a platform and strong foundation for the optimization of small molecule leads as therapeutic candidates to prevent influenza virus infection and pandemic threats.